Central Factors in Auditory Masking

7. Project Summary/Abstract The purpose of this work is to obtain a better understanding of the communication difficulties experienced by listeners with sensorineural hearing loss in complex, multisource acoustic environments. The basic premise upon which this research is based is that much of this difficulty is due to an interaction between peripheral hearing loss and more centrally-based processes responsible for source segregation, focused and divided attention, and working memory. On a theoretical level, our view is that the competition between sound sources may be characterized according to a distinction between two basic mechanisms of masking: energetic masking, which is primarily due to overlapping patterns of excitation in the auditory periphery; and informational masking, which results from the limitations on processing at later stages in the auditory nervous system and brain. This distinction is pervasive in auditory tasks affecting simple detection, discrimination and identification, and speech recognition. On a general level, both peripheral and central factors in masking affect the formation, maintenance, and processing of sequences of related auditory events, or streams and a theme throughout this work is to understand more fully the processing of sequential information. The approach taken here is to attempt to evaluate the influences of energetic and informational masking on performance in a variety of tasks placing demands at different levels oaf the auditory system. The long-range goal is to develop an integrated theory of auditory masking that accounts for energetic and informational masking generally and successfully predicts the consequences of cochlear hearing loss.

Public health relevance
Project Narrative This work addresses the common problem of hearing loss and its effects on communication in group situations. Although hearing loss, whether assisted by hearing aids or not, may have minimal impact on communication when talking one-on-one in a quiet setting, it is often devastating when talking to one or more persons in noisy group situations, such as meetings, parties, social functions, etc. Our work examines the effects of hearing loss in group situations with particular emphasis on how hearing loss stresses cognitive processes such as attention and memory and the interference and distraction caused by noise. __SpecificAimsTextDelimiter__ 2. Specific Aims (1 page) 1) To Examine the Processes Underlying Masking in Listeners with Normal Hearing and the Interaction of Hearing Loss and Masking in Listeners with Sensorineural Hearing Loss. This study is focused on separating and understanding peripheral and central factors in masking. In much of the proposed work, as has been the case with past work from this research group, new methods and stimuli, or adaptations of existing methods, are used to reveal the actions of different mechanisms causing masking. In order to fully understand the normal function of hearing in complex acoustic environments and, additionally, to explain why hearing loss causes such functional difficulty in communication in complex environments, the nature of the competition and interference among sound sources must be determined. Although masking has been studied in detail throughout the history of modern auditory psychophysics the significance of the distinction between two underlying mechanisms of masking, peripherally-based energetic masking and centrally-based informational masking, has only recently become clear (please refer to Kidd et al., 2008a, for a recent review of this topic). Furthermore, very little is known about energetic and, particularly, informational masking in listeners with sensorineural hearing loss. A case will be developed supporting the critical importance of the latter for understanding the demands imposed by real-world communication. The first aim is to study energetic and informational masking in auditory tasks spanning a range of complexity, including detection, nonspeech pattern identification, and speech recognition. This aim tests the hypothesis that listeners with sensorineural hearing loss experience greater than normal informational masking, or are less able to use cues that normally provide release from informational masking, after taking into account energetic masking. 2) To Examine the Consequences of Sensorineural Hearing Loss on the Processing of Sequences of Sounds. Most typical communication situations involve the comprehension of information contained in specific sequences of sounds. The elements of such sequences are linked together over time to form distinct perceptual entities. The second aim is to extend our knowledge of the formation, segregation, maintenance over time, and extraction of information from sequences of related sounds, or "auditory streams." The focus of the work is to determine how streaming is affected by competing sounds and how this process is affected by sensorineural hearing loss. An underlying hypothesis is that listeners with SNHL will exhibit greater loss of information as rate increases under conditions of high IM and ask whether sensorineural hearing loss imposes special limitations on the processing of sequentially-occurring sounds. Implicit in this hypothesis is that these limitations are less obvious for sounds presented in isolation or become more pronounced when isolated sounds are connected into sequences. Sounds of interest to the listener - "targets" - usually occur under various forms and levels of context, ranging from the acoustical "surround" of both target and nontarget ("masker") elements to the more complex syntactic structure and linguistic content of speech. These contextual effects, which consist of both bottom-up peripheral processes and top-down central processes, often provide a significant aid to normal communication. This aim also addresses the question: how can context aid listeners in solving complex auditory tasks under conditions of high informational masking? The goal is to further our understanding of the benefit of contextual effects of varying levels of complexity in the processing of sound sequences in general and to extend this understanding specifically to the benefit afforded to listeners with hearing loss. 3) To Examine Individual Differences in the Susceptibility to and Release from Informational Masking. The influence of central factors on masking characteristically is manifested by very large individual differences in performance. In this aim we plan to investigate the origins of individual differences under conditions producing large amounts of informational masking. The hypotheses include that 1) listeners may reliably be characterized according to the degree of "susceptibility" to informational masking across auditory tasks, 2) listeners with sensorineural hearing loss are more susceptible to informational masking than listeners with normal hearing, and 3) there are reliable differences among subjects in the degree to which stimulus- based cues lead to release from informational masking and those differences are consistent across tasks. The goal is to determine patterns of individual behavior on tasks thought to be limited primarily by central processing factors and to assess the effects of hearing loss on these abilities.